VIAGRA IN DIABETICS W/ ERECTILE DYSFUNCTION

To assess the efficacy, safety, quality of life, and patient and partner satisfaction with VIAGRA TM(sildenafil) taken as required prior to sexual activity in male diabetic outpatients with erectile dysfunction.